Convoy: A Cultural approach of Navajo Youth to Biomedical Sciences

- 5 R25GM150141-02; Hakim, Shazia Tabassum
Modified Project Summary/Abstract Section

Summary/ Abstract: Project Title: “CONVOY: An Educational approach of Youth to Bio- medical Sciences”. Need Assessment: STEM Learning Ecosystems are localized multi-stakeholder collaborative networks (MSCNs) that are “dynamic collaborations among schools, out-of-school time programs, STEM expert institutions, the private sector, community-based organizations, youth and families”, and has been identified as one of the key sources to harvest human capital and contribute to novel interventions through the development of advanced knowledge. We will create a bridge between traditional knowledge and modern biomedical science via “CONVOY”. Peer Groups: Numerous peer groups focus on the development of K-12 and undergraduate research and education programs, but there are very few who are focusing on healthcare and biomedical sciences. This proposed activity provides students with research experiences, hands-on laboratory training, and other educational and communication opportunities via Science Café and Health Fairs to prepare them for future leadership and careers in healthcare, biopharma, and other associated professions. Proposal: “CONVOY” project brings together students from Junior high schools, high schools (mentees) and Diné College (mentor avatars) in order to spawn their enduring curiosity in biomedical and health sciences —— while adapting the concept of “near-peer” network to bring forward the local health issues to the open forums.

Public health relevance
SEPA-CONVOY will guide junior high and high school students toward biomedical sciences, public health, allied healthcare, and STEM careers. The program emphasizes problem-solving, innovation, and practical application of ideas. The near-peer model pairs Diné College students with younger learners to develop leadership skills and create clear pathways to higher education in biomedical sciences.